A Virtual Project-Based Learning Sandbox for Mimetics and Medically Inspired Classroom Engineering (MiMICRE)

Project Summary/Abstract: The U.S. has more health science STEM jobs available than qualified workers
to fill them and lags other OECD nations in math and science, with major achievement gaps and STEM
workforce under-representation among women and students of color. Improved STEM education is needed
in high school and early collegiate settings that engages, prepares, and inspires all students—and especially
under-represented groups. 21st-century STEM jobs require not only STEM content knowledge but also
problem-solving, critical thinking, and teamwork. Research has shown that team collaboration and application
of STEM to problems in communities are effective at improving STEM outcomes in under-represented groups.
Downstream, the follow-on effects of the COVID-19 pandemic have exacerbated STEM degree program
recruitment and retention issues (especially among under-represented groups). Parametric Studio Inc. (PSI)
believes collaborative game-based project learning experiences have the potential to address STEM
deficiencies and under-representation while better preparing the future health science STEM workforce.
However, innovations to project-based learning to add better connections to industry tools, improve
engagement, ease implementation issues, reduce cost, and enhance authenticity or realism are needed.
The overall goal of this multi-phase SBIR project is to develop, validate, and commercialize MiMICRE, a
game-based STEM project learning platform that can address current deficiencies in project-based learning
(PBL). MiMICRE utilizes applied math and science in the design, analysis, and simulation of bioscience,
engineering, and biomimicry-focused STEM projects. In MiMICRE, users collaboratively design product
solutions, apply math and science models to evaluate them, and then 3D-print and test results in the real
world. Ultimately, MiMICRE will be sold to high school, post-secondary, and informal Ed. markets.
This Phase II SBIR project is based on Phase I proof-of-concept success that demonstrated the
functionality of key MiMICRE components and showed that platform elements are usable by students and
teachers. Deployment in the classroom was validated: Phase I prototype testing produced several early
indicators of improved student engagement, efficacy, and STEM content knowledge. Phase II work will thus
focus on the following Aims: 1) develop Phase II enhancements to the MiMICRE Phase I prototype that
will promote widespread adoption in high school and early collegiate settings; 2) show that third-party
MiMICRE projects can be quickly defined for customers; and 3) conduct larger pilots to evaluate
improvements in STEM knowledge, STEM interest and efficacy, and perceived connection of skills and
knowledge to future STEM employment. Phase II will result in a completed, tested solution for improved
STEM project-based learning in high schools and colleges. Phase II success is critical in terms of product
validation, attracting follow-on private-sector investors/partners, and ultimate product commercialization.

Public health relevance
Project Narrative: The U.S. has more health science STEM jobs available than qualified workers to fill them and lags other OECD nations in math and science, with major achievement gaps and STEM workforce under- representation among women and students of color. With its successful Phase I SBIR results, Parametric Studio Inc (PSI) proved the functionality, feasibility, and usability of MiMICRE, a game-based project platform that uses collaborative bioengineering projects to help address STEM deficiencies, promote 21st-century skills, and reduce under-representation in the future health science and STEM workforce. The PSI team now proposes a Phase II project that will allow the PSI team to complete full development of MiMICRE with all fully tested/validated STEM- related features and capabilities needed for commercial investment and deployment.